Fermented wheat germ proteins;mechanistic, immunologic and pre-clinical canine studies

Approximately 33% of adults in the U.S. have used complementary health approaches (NHIS, CDC [4-6]).
In doing so, 59 million Americans spend $30.2 billion out-of-pocket/year. The most commonly used
complementary approach are natural products ($12.8 billion-almost one fourth of the out-of-pocket amount
spent on all prescription drugs combined). Moreover, recent studies have found that CAM use is highly
prevalent in this and many other countries with 36-52% of the population using CAM at some time [29]. Despite
their frequent use and significant impact in healthcare dollars, scientific research has provided scant evidence
for benefit of natural products in cancer therapy.
An aqueous extract of wheat germ fermented with Saccharomyces cerevisiae (FWGE) is sold in the U.S.
as a dietary supplement (trade name: Avemar). FWGE is cytotoxic to several human cancer cell lines [7-16]; in
vivo efficacy has been reported for colorectal carcinoma [17-21], melanoma [22] and squamous cell carcinoma
[20] and preliminary clinical data is promising [17, 22, 23]. FWGE reportedly has “immune-reconstructive”
effects [17, 22, 24, 30-32]. These conclusions, however, are mostly based on single-experiment studies devoid
of rigorous follow-up. It has been proposed that FWGE activity is based on its content of
dimethoxybenzoquinone (DMBQ) [24-27]. However, this has not been proven, and indeed early studies
indicated that DMBQ alone cannot be responsible for the immunostimulatory properties of FWGE [24] and may
in fact have significant toxicity [33-35].
We have confirmed that FWGE has remarkable anti-tumor activity in NHL models in vivo especially when
used in combination with the monoclonal antibody (mAb) rituximab. The efficacy of FWGE was comparable to
that of the aggressive R-CHOP regimen, but FWGE had no appreciable toxicity. Our published results suggest
that a protein fraction from fermented wheat germ (FWGP), not DMBQ, is responsible for this activity by, at
least in part, stimulating natural killer (NK) cell-mediated tumor eradication in vivo [28]. This is a significant
observation since abnormal NK cytolytic activity has been described in hematological malignancies [36].
The overall goal of this proposal is to isolate active component(s) in FWGP and to understand its
tumoricidal effects by examining activity/toxicity in vivo in canine NHL and ex vivo in humans in anticipation of
human clinical trials.
Significance for the VA population
We have shown that FWGP is effective against NHL, both in vitro and in vivo [28]. NHL is the sixth most
common cause of cancer-related death in the United States [1-3]. The fastest growing segment of the
population acquiring this disease is elderly males (a substantial segment of the VA patient population). Given
this, and the fact that NHL is an agent orange-associated malignancy, the impact on veterans is substantial.
We also have substantial preliminary data suggesting that FWGP is effective in pre-clinical models of non-
small cell lung carcinoma (NSCLC). NK cell anti-tumor activity in lung cancer is increasingly being recognized
as an actionable clinical target [44-47]. While the focus of this proposal is on NHL, our results could have
substantial impact in the treatment of NCSLC. Lung cancer is the most common cause of cancer-death world-
wide world [48, 49] in both men and women. NSCLC represents ~85% of all lung cancers. Approximately 2/3
of the patients have advanced or metastatic disease at the time of initial presentation [50]. Survival rates are 2-
20% depending on stage [51, 52]. Current chemotherapy bears significant toxicity. Checkpoint inhibition has
revolutionized oncology, but up to two thirds of NSCLC patients fail to respond or eventually relapse. This
proposal lays the groundwork for development of new, effective, and non-toxic treatment approaches for NHL
and NSCLC , which are directly applicable to the VA patient population.

Public health relevance
Many patients, especially the elderly, tolerate chemotherapy poorly--a finding that has been demonstrated to limit efficacy and the possibility of cure. The development of less toxic treatments or non-toxic therapies that make standard therapy work better is very relevant. This proposal lays the groundwork for development of new, effective, inexpensive, and less-toxic treatment approaches for lymphoma, lung cancer and other malignancies that are commonly found in veterans. Approximately 250,000 people in the USA have NHL and over 400,000 with lung cancer. While there have been advances in treatment for both diseases the vast majority still succumbs to their diseases. The fastest growing segment of the population acquiring this disease is elderly males (a substantial segment of the VA patient population) that tolerate chemotherapy poorly. Novel more effective, less toxic and inexpensive agents are needed. Given this, and the fact that NHL is an agent orange-associated malignancy, the impact on veterans is substantial.